Michigan Center for Urban African American Aging Research (MCUAAAR) Diversity Supplement (Kimson Johnson)

PROJECT SUMMARY
This application seeks support for a doctoral candidate in Health Services Organization and Policy and
Sociology, Kimson Johnson, into an NIA funded project through a Research Supplement to Promote Diversity in Health‐
Related Research. The NIH parent grant for which this supplement will rely on is the Michigan Center for Urban African
American Aging Research (MCUAAAR) led by Drs. Robert Joseph Taylor at the University of Michigan and Peter
Lichtenberg at Wayne State University. MCUAAAR is one of the NIH funded Resource Centers for Minority Aging
Research (RCMAR). The application describes the mentoring model used by the MCUAAAR and the planned mentoring
experiences for the candidate, as well as describes the candidate and the proposed research on brain health in older
African Americans.
The overarching objectives of this research proposal are to (1) identify the relationship between adverse
childhood experiences (ACEs) and cognitive functioning in later life, (2) identify the relationship between
adverse adult experiences (AAEs) and cognitive functioning in later life, and (3) determine how race/ethnicity moderates
the relationship between adverse life experiences and cognitive functioning in later life. This study utilizes longitudinal
population‐level analysis to identify how adverse life experiences via traumatic and stressful childhood and adulthood
pathways impact late‐life cognitive functioning.
The study will serve as the dissertation for the candidate Kimson Johnson, an African American doctoral
candidate in Health Services Organization and Policy and Sociology at the University of Michigan. The
MCUAAAR faculty will provide a series of integrative mentoring experiences under the guidance of a mentoring team of
Dr. Robert Joseph Taylor the PI of MCUAAAR, Dr. Peter Lichtenberg, Co‐Director of the MCUAAAR, and an expert in
dementia among African Americans. She will also be mentored by Dr. Jacqui Smith, a Co‐PI of The Health and Retirement
Study (HRS).

Public health relevance
RELEVANCE Previous studies have shown the lasting health effects of adverse life experiences (ALE) on physical and mental health over the life course. However, little is known about the distal effects of self-reported adverse life experiences in childhood and adulthood on cognitive functioning in older populations across racial/ethnic groups of older adults in the United States. Understanding how the long-term consequences of adverse experiences influence cognitive function trajectories in later life can inform and enhance health promotion and disease prevention programs.